Charting the Path to Health in Midlife and Beyond: the Biology and Practice of Wellness

PROJECT SUMMARY The NIH's mission to apply knowledge about the nature and behavior of living systems to enhance health, lengthen life, and reduce illness and disability is complemented by the National Institute on Aging's mission to extend healthy, active years of older adults' lives, specifically to ` disseminate information about aging and advances in research to the public, health care professionals, and the scientific community, among a variety of audiences'. The University of Colorado School of Medicine (CUSOM) is home to the state-of-the-art Anschutz Health and Wellness Center (AHWC), a national Nutritional and Obesity Research Center (NORC), a Center for Women's Health Research, dedicated to research in women's health, and a new, University of Colorado Hospital $150 million campaign to promote behavioral health services. The close alignment of these national and local missions provides an opportunity to create an innovative, synergistic translational science symposium to be held immediately before the North American Menopause Society's (NAMS) 2020 annual meeting in Denver, CO. The symposium, `Charting the Path to Health in Midlife and Beyond: the Biology and Practice of Wellness' will address gaps in knowledge about how the science and practice of wellness may be applied to enhance midlife women's health and lengthen life and will be held in Denver, CO, before the North American Menopause Society's 2020 Annual Meeting. Specific Aims are to: 1. Utilize a diverse array of faculty to provide a novel, foundational framework for the concept of `wellness' and behavioral approaches to promote healthy aging; 2. Enable practitioners to translate research content into clinical practice; 3. Facilitate attendance of trainees and junior faculty to engage them further in health promotion; and 4. Disseminate the information presented in formal academic pathways and through online platforms that provide high-quality content. Materials will be disseminated via formal publication and multimedia presentations. This symposium will address common concerns of midlife women and their providers and provide diverse, interdisciplinary expertise to promote interaction and application of new science to all patient populations.

Public health relevance
PROJECT NARRATIVE This proposal will fund an interactive conference to teach healthcare workers how to help women in midlife, at menopause and beyond, to achieve a state of `wellness' defined as a state of being that includes strong social connections, healthy lifestyle behaviors, an ability to handle stress and bounce back, and emotional and physical health.